Forsyth Student Scholars Summer Internships in Oral Health Research

Oral health disparities disproportionately impact communities of color and other low-income communities. US
school systems have systemic inequities which lead to differing outcomes for students based on opportunity,
which has profound and long-lasting consequences. This lack of access and opportunity continues to have
profound impacts on our national potential. Since 1993, the ADA Forsyth Student Scholars (FSS) program has
prepared high school students from these communities for science and research programs in college. Our
program aims to: 1) present science, scientists, and oral health providers as multi-faceted, diverse, and
accessible, 2) increase basic research understanding and the career opportunities it creates, 3) foster increased
comfort levels in approaching science- and oral health-related concepts and activities, 4) encourage feelings of
inclusion and belonging in science and oral health careers, and 5) elevate awareness of RCR and DEIB issues
in the science and oral health as a component of professional awareness. The FSS Program is comprised of a
mentored research project and training modules on laboratory research skills, science and oral health seminars,
and college/career readiness skills. Unique and innovative attributes of the FSS High School Program include
individualized mentoring, student involvement in cutting-edge research, technology development training, soft
skills development, networking opportunities within Boston and with local University students and leadership,
and an emphasis on outreach and public health dentistry, understanding oral health disparities, and how to
address them. The FSS program curriculum is updated yearly for evidence-based improvement to optimize
learning outcomes for our students, using individual needs assessments and program evaluations from both
students and mentors. The long-term goal is to increase the pool of students from underrepresented and
educationally disadvantaged groups in oral health research. At the same time, the project helps to raise oral
health awareness in our communities, helping the next generation of dentist-scientist researchers develop cross-
cultural mentoring skills. Applicants are recruited to the FSS program through outreach events, visits to high
schools in under-resourced Massachusetts communities, and partnerships with community and education-based
organizations. Of the almost 60% of FSS alumni followed in 30 years of programming, 86% are currently working
in science, and 53% have completed graduate, medical, dental, or professional school. While having many of
the same components, the increased rigor of the undergraduate program will help prepare students for further
study in public health and/or the sciences. This proposal seeks funds for ten high school students in the FSS
Program. To reverse the education and oral health disparities epidemic, we must address the causes of health
inequities by improving access to and the quality of dental care, developing a culturally competent workforce,
and supporting efforts to address underlying socioeconomic inequality. The ADA Forsyth Student Scholars
Program aims to increase students' readiness for college, professional school, and the oral health workforce.

Public health relevance
Oral health inequalities disproportionately impact communities of color and other low-income communities. The long-term goal of The ADA Forsyth Institute Student Scholars Program is to increase the workforce of underrepresented and/or educationally disadvantaged groups in oral health research. The FSS program will support students as they enter college and help the next generation of dentist-scientist researchers develop cross-cultural mentoring skills.